University of Florida R25 Early Research Program for Neurology and Neurosurgery Residents

Abstract
The next generation of academic leaders in Neurology and Neurosurgery residency programs will
require expert research training and mentorship in order to achieve a balanced academic career.
Unfortunately, most training programs are better suited to develop the clinician and not prepared
to mentor the clinician-researcher or to offer him/her the dedicated time necessary to develop an
academic research project. There is a danger of the disappearing clinician-scientist and this
danger in a reality in many institutions based on an ever increasing patient care demand and a
shortage of neurologists and neurosurgeons. The University of Florida neurology and
neurosurgery residency programs have adopted an infrastructure to identify resident researchers
early in their training and to advance them toward K awards. This early identification coupled with
a milestone driven approach has provided a formula for the success of residents interested in
research career paths. This NINDS R25 application from the University of Florida (UF) will focus
on the development of a comprehensive early research program to meaningfully engage
neurology and neurosurgery residents in research from day 1 of their internship all the way
through their residency, fellowship, and successful K award application. This project will provide
the potential UF R25 individual applicant access to an ideal research environment with protected
time, coursework, mentorship and a strong institutional commitment. UF offers outstanding
basic/translational laboratory experiences, clinical research, research facilities, and an expert
mentor-mentee experience. Potential R25 enrollees at UF will have access to a freestanding
neuromedicine hospital, multiple interdisciplinary clinics with significant research/clinical trials
infrastructure, and the core facilities of the McKnight Brain Institute. The potential R25 participant
will be identified early in their residency training, placed on a research track and mentored toward
a dedicated research experience and ultimately a NIH K award.

Public health relevance
Project Narrative This NINDS R25 application from the University of Florida (UF) will introduce a comprehensive early research program for neurology and neurosurgery residents that will engage the trainee on their first day of residency. UF R25 recipients will have access to an ideal research environment with protected time, coursework, mentorship and a strong institutional commitment. The potential R25 participant will be expected to achieve defined milestones that will lead to a dedicated and meaningful research experience and ultimately a NIH K award.